Regulation of lysosomal potassium channels

Program Director/Principal Investigator (Last, First, Middle): Ren, Dejian
The major goal of the proposed research is to understand how the ion channel TMEM175 we discovered
controls lysosomal function and regulates neurodegenerative diseases. Lysosomes are uniquely important for
many functions such as material digestion, recycling, cellular clearance, exocytosis, wound repair, Ca2+
signaling, nutrient sensing. They are also the platform for signaling networks involving the mTOR and AKT
kinases and transcription factor TFEB. Lysosomal dysfunctions are implicated in numerous diseases such as
lysosomal storage and neural degenerative diseases, and is a hallmark of aging. Despite the importance, their
biophysical properties have been poorly defined, and there are several “controversies” even in processes as
basic as acidification. We have recently started to fill the knowledge gap by using organelle electrophysiology,
channel protein discovery and functional studies in mice and human. In the past period, we have focused on
the TMEM175 protein that we discovered to form the K+ channel we first recorded. TMEM175 is a major locus
linked to several neurodegenerative diseases including Parkinson's disease (PD) and Lewy body dementia.
We found that TMEM175 is important for the acidification of lysosomes. TMEM175 knockout (KO) neurons are
prone to stress-induced damages and have accelerated spreading of misfolded α-synuclein. KO mice lose
dopaminergic neurons, a hallmark of PD. We also found that a PD-associated variations affect lysosomal ion
channel function and modulate Parkinson's disease pathology. Thus, TMEM175 is important for lysosomal
function and neuronal fitness, and bidirectionally regulates neurodegenerative diseases. We propose to further
reveal how TMEM175 is activated by the kinase protein AKT (Aim 1), how the channel contributes to lysosomal
function such as acidification (Aim 2) and how its genetic variations contribute to variations in neuronal function
and neurological diseases (Aim 2). As TMEM175 is implicated in PD and several other neurodegenerative
diseases, the work will also reveal how genetic variations contribute to functional variations of lysosomes and
neuronal fitness, and will provide foundation for the intervention of neural degeneration diseases.
Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Ren, Dejian Lysosomes are important to many aspects of cellular function, and dysfunction in lysosomes results in diseases such as lysosomal storage diseases and neurodegeneration. The proposed research will determine the molecular mechanisms by which the lysosomal potassium channel protein TMEM175 is regulated and how the channel contributes to lysosomal function and neurodegenerative diseases. The studies will lead to discoveries related to neurodegenerative diseases and will provide foundation for disease intervention. Page